Quantitative 'Omics Core

ABSTRACT
QUANITATIVE OMICS (QOC) CORE: The field of precision medicine offers the promise of improving the health
of patients through targeted treatments and therapeutics based on the unique characteristics of the individual.
Due to its nature, precision medicine studies frequently require custom solutions and novel
statistical/bioinformatics methods. For the same reason, they require cross-disciplinary data scientists with a
“team-science” background to facilitate both a comprehensive understanding of the needs of domain experts
and the requisite technical expertise to support those needs by applying state-of-the-art data science methods
and, when necessary, develop custom solutions. The Quantitative ‘OmiCs (QOC) Core has been formulated to
address these needs by providing high-quality data science support to the Kansas Institute of Precision Medicine
(KIPM). In this Phase 2 application, the QOC Core will seek to expand its expertise to include artificial
intelligence, deep-learning, analysis of proteomic and metabolomic data, and molecular modeling guided by the
new RPLs associated with this application. In addition, the QOC Core will collaborate with other institutional
cores to pool resources, expanding its repertoire of research supporting tools and technologies and enhance its
computing infrastructure. This serves both the data science needs of the RPLs and contributes to the long-term
sustainability of the QOC Core by broadening the scope and quality of its services. Finally, this Core will seek to
recruit users beyond the KIPM to assure its long-term operation.